Neural and behavioral mechanisms of obesity development from infancy through childhood

PROJECT SUMMARY
Obesity risk shows individual variation such that some children are more likely than others to gain excess
weight. One potential reason is that, due to genetic and environmental factors, individuals vary in appetitive
behaviors that drive food intake and weight. However, the neurodevelopmental mechanisms underpinning
variation in appetite and weight, and effects of risk and protective factors on those outcomes, are not understood.
Preliminary data from RESONANCE, our large MRI cohort, suggests obesity risk factors (maternal pre-
pregnancy obesity, obesity-associated genetic variants) are associated with not just heightened parent-reported
child appetite and BMIz, but with slower global myelination, decreased gray matter volume within fronto-cingulate
control circuits, and increased volume in striatal reward regions, from infancy through early childhood. However
the relevance of these findings to appetitive behaviors and development of obesity in middle childhood is
unknown. This is important because obesity rates and metabolic complications increase through development,
adiposity and eating habits measured in later childhood track into adulthood, and obesity is harder to treat later
in development, making middle childhood a key stage for capturing outcomes with relevance for lifetime
metabolic health. Further, although task fMRI studies have identified altered patterns of activation in brain
appetite circuits in association with pediatric obesity and early risk factors for obesity, the predictors of altered
functioning of brain appetite circuits in middle childhood are unknown. Identifying the patterns of brain
development that predict obesity-promoting behaviors and brain functioning in middle childhood is essential to
understand the neural mechanisms by which early obesity risk factors drive excess intake and obesity, and may
help pinpoint neurobehavioral targets for early obesity prevention. Finally, although preclinical research and MRI
studies of children >9y support that hypothalamic gliosis, a cellular inflammatory response, plays a role in obesity
pathogenesis, it is unclear whether it occurs or impacts appetite in earlier life. For the proposed study,
RESONATE, we will address the above research gaps by extending the RESONANCE study to administer meal
tests, behavioral and fMRI tasks assessing food and non-food reward and cognitive control, and weight/adiposity
measures in middle childhood, and examining hypothalamic gliosis, in a sub-sample of RESONANCE children.
By combining this data with extant MRI data and extant or newly-collected data on obesity risk and protective
factors, we will test a multi-faceted hypothesis that prenatal, genetic and postnatal factors lead to differential
early development of brain appetite circuits, which in turn gives rise to variation in appetitive behaviors and
behaviors involving reward processing and cognitive control as well as altered function of brain appetite circuits,
that act to influence the development of obesity into middle childhood. Our long-term goal is to lay foundations
for developmentally-appropriate, neurobehaviorally-informed interventions to address child obesity.

Public health relevance
PROJECT NARRATIVE Our project, RESONATE, aims to investigate why some children develop obesity. To do this it uses data on eating and eating-related behaviors, genetic and environmental factors, and brain structure and function, collected in a sub-sample of RESONANCE, a large study of families of children from infancy through childhood. The results will lay foundations for the development of early interventions to prevent or treat obesity.